EVOLUTION IN MICROBES--POPULATION STRUCTURE AND GENETICS

The long-term objectives of this project are to understand the process of evolution in asexual micro-organism populations and their genetic structure.